Identifying therapeutic targets that confer synaptic resilience to Alzheimer's disease

Project Summary
Approximately one-third of individuals without dementia at the time of death are found to harbor high levels of
Alzheimer’s disease (AD) pathology at autopsy. We hypothesize that such individuals exhibit physiological
resilience that confers the ability to maintain cognitive function despite the accumulation of AD-related
pathologies. The identification of the specific mechanisms by which these older individuals with AD pathology
avoid dementia is one of the most pivotal, unanswered questions in the field. Cognitive impairment in AD is the
result of synapse loss in brain regions that are critical for memory processes. Our work and that of others has
demonstrated that dendritic spine and synapse loss correlate more strongly with cognitive impairment in AD than
accumulation of amyloid-β (Aβ) plaques and neurofibrillary tangles. This implies that the ability to maintain
cognitive function despite substantial AD neuropathology must be linked to the preservation and maintenance of
synapses or spines across vulnerable brain regions. This raises important questions: 1) What are the synaptic
signaling pathways that maintain cognitive abilities in resilient individuals? 2) How do Aβ and tau interact with
dendritic spines to influence the brain connectivity that facilitates resilience? 3) Can we identify protein targets
for therapeutic development that support cognitive functions across brain regions? Thus far, few molecules have
proven effective for Alzheimer’s disease, where the goal is improving high-level, brain-spanning cognitive
phenotypes. This big picture challenge of therapeutic target selection could be solved by pursuing molecules
predicted to affect connectivity across brain regions, thereby improving the likelihood to affect cognitive status.
Thus, the goal of this proposal is to identify key molecular mechanisms that support resilience to Alzheimer’s
disease across multiple brain regions, and then carefully validate these findings by testing their relevance in
computational, cellular, and animal models. In the previous funding cycle, we generated unprecedented data on
functional magnetic resonance imaging and brain multi-omics from the same human subjects, which
demonstrated that it is possible to combine postmortem molecular and subcellular data with antemortem
neuroimaging to prioritize mechanisms underlying brain connectivity. Now, it is essential to identify the molecular
and cellular mechanisms that support resiliency to Alzheimer’s disease and understand how Aβ and tau affect
connectivity patterns of resilience.

Public health relevance
Project Narrative The number of older adults suffering from Alzheimer’s disease is expected to rise unless new treatments are developed which can prevent or delay the onset of dementia. Investigating the molecular and cellular mechanisms that support resiliency to Alzheimer’s disease will reveal new therapeutic targets to halt disease progression in at risk patients.